Role of ctDNA change as a response measure in the EA1183 patient population and how ctDNA changes correlate with metabolic response by serial FDG PET/CT

Project Summary:
Patients with bone dominant (BD) and bone only (BO) metastatic breast cancer (MBC) represent a large
patient population1,2 who are often excluded from clinical trials using RECIST 1.1 as the primary response
assessment because bone lesions are classified as non-measurable, non-target lesions3. Current blood-based
biomarkers such as tumor markers (CA15.3, CA27.29 and CEA) have similarly shown limited utility in
assessing response to therapy in patients with MBC. There is therefore an important need for better measures
of therapeutic response for patients with BD MBC. EA1183 FEATURE is a prospective, multicenter clinical trial
approved by the NCI and sponsored by ECOG-ACRIN designed to evaluate the value of serial FDG-PET/CT to
assess response in BD MBC. The trial will test the ability of tumor metabolic changes to predict the clinically
meaningful outcomes of progression free survival (PFS) and time to skeletal-related event (tSRE).
Measurement and characterization of ctDNA provides an option of non-invasively evaluating both disease
burden and emergence of genomic changes in tumor biology. We propose to integrate fluid-based tumor
monitoring (by serial collection of circulating tumor DNA, ctDNA) and FDG-PET/CT imaging to determine if
these biomarkers, separately or combined, can predict a response to therapy for in patients with BO or BD
MBC participating in the EA1183 FEATURE trial. We will also assess the extent to which FDG-PET/CT,
ctDNA, or both can predict PFS as early as 4 weeks into therapy. We hypothesize that integration of imaging
(FDG-PET/CT) and fluid-based, liquid biopsy (ctDNA) assays may permit characterization of therapy response
for patients with BO and BD MBC in advance of currently used methods, possibly as early as 4 weeks. This
R01 proposal will provide support for additional objectives in EA1183, which are the aims of our proposal: 1.) to
assess ability of qualitative and quantitative changes in serial ctDNA measures to predict PFS and time to SRE
in patients with BO or BD MBC beginning new systemic therapy in EA1183; 2) to determine if early metabolic
changes in bone metastases assessed by FDG-PET/CT at 4 weeks after start of systemic therapy predict PFS
and tSRE in patients with BO or BD MBC; 3) to evaluate the relationship between changes in ctDNA and
metabolic response as assessed by FDG-PET/CT and to test the combined ability of FDG-PET/CT and ctDNA
at 4 and 12 weeks after the start of new systemic therapy to predict PFS and SRE. The outcome of this study
will be the generation of robust response endpoints for BD MBC to provide access to clinical trials and guide
clinic al practice for the large group of patients with this type of MBC.

Public health relevance
PAR-19-363, Integration of Imaging and Fluid-Based Tumor Monitoring in Cancer Therapy (R01 Clinical Trial Optional) Project Narrative: Assessing response to therapy in patients with bone-only (BO) or bone- dominant (BD) metastatic breast cancer (MBC) is hampered by absence of easily measurable disease by standard imaging criteria and by lack of effective blood biomarkers (i.e., tumor markers). This proposal will integrate fluid-based tumor monitoring (by serial collection of circulating tumor DNA, ctDNA) and FDG-PET/CT imaging to determine if these biomarkers, separately or combined, can predict a response to therapy for in patients with BO or BD MBC in the context of a multi-center, prospective clinical trial, EA1183 (FEATURE).